Regulation of spore peptidoglycan modification

Dr. Gabrielle Valles recently received her Ph.D. from the University of Connecticut, where she used NMR
spectroscopy and X-ray crystallography to study the structure and function of a eukaryotic deubiquitinase. We
are requesting funding for a Research Supplement to Promote Diversity in Health-Related Research because
Dr. Valles is an African-American woman and US citizen and thus underrepresented in the biomedical sciences.
Dr. Valles will join Dr. Aimee Shen’s laboratory to work both on the parent grant (R01 GM140361-02) and an
extension of this grant based on recent unpublished work. The central focus of the parent grant is to delineate
the mechanisms by which spore-forming bacteria control the activity of a highly conserved, spore-specific
amidase, CwlD. Our lab previously showed that CwlD activity in the important nosocomial pathogen,
Clostridioides difficile, depends on a binding partner conserved exclusively in the Peptostreptococcaceae family,
the GerS lipoprotein. Our recent crystal structure of the CwlD:GerS complex (solved in collaboration with Co-
Investigator Dr. Sylvie Doublié) reveals that GerS binds at a site distal from CwlD’s active site in this structure
(Aim 1a). Accordingly, the revised objective of the parent grant is to determine how GerS binding at an allosteric
site is communicated to CwlD’s active site. To accomplish this goal, Dr. Valles will conduct structure-function
analyses of CwlD, GerS, and the CwlD:GerS complex using NMR spectroscopy, X-ray crystallography,
mutagenesis analyses in C. difficile, B. subtilis, and E. coli, and co-immunoprecipitation and fluorescence
microscopy analyses. Most of these techniques were proposed in the parent grant, but the NMR analyses will
leverage Dr. Valles’ training during her graduate work. Through this work, Dr. Valles will learn bacterial genetic,
cell biology, and peptidoglycan analysis techniques for which she has no prior experience. She will take two
immersive, hands-on short courses to supplement this training on bacterial genetics and microscopy.
The proposed research training and career development plan will allow Dr. Valles to establish a productive
research program for her future independent academic position. By the end of her research training, Dr. Valles
will be uniquely positioned to conduct bona fide structure-function analyses in bacteria because few scientists
have the combined training needed to solve structures and conduct structure-guided mutational analyses in the
organism of interest. This interdisciplinary training will enhance Dr. Valles’ competitiveness for faculty jobs
because most structure-function studies involve a collaboration between a biologist and a structural biologist. To
prepare for this future career, Dr. Shen will help Dr. Valles further develop the non-research skills that will allow
Dr. Valles to thrive in her future academic research position, e.g. manuscript preparation, oral presentation, grant
writing, mentoring, teaching, networking skills. Collectively, this personalized training plan will ensure that Dr.
Valles achieves her long-term career goal of becoming a tenure-track professor committed to research, training,
and increasing diversity and inclusion in the biomedical workforce.

Public health relevance
The personalized Research Experience Plan Dr. Shen and Dr. Valles have developed will ensure that Dr. Valles achieves her long-term career goal of a becoming a tenure-track professor that conducts research and teaches. As an African-American woman underrepresented in the biomedical science, Dr. Valles will serve as a mentor and inspiration to students from underrepresented backgrounds pursuing careers in the biomedical science and thus improve diversity in the biomedical workforce.